Identifying facilitators of coordinated care for survivors of intimate partner violence: Formative research towards intervention development

PROJECT SUMMARY
Coordinated care, the process of identifying at-risk individuals and connecting them with health and social
services at the point of care, is an important evidence-based approach for optimizing service connection and
retention among individuals at highest risk for poor health outcomes. Survivors of intimate partner violence
(IPV) —a group with complex needs—would likely benefit from such care; while IPV coordinated care has
been theorized it has not to date been operationalized. Emergency departments (EDs) provide vital and often
life-saving care to people experiencing intimate partner violence (IPV) making them an opportune setting to
disrupt IPV through intervention. Where EDs meet the acute medical care needs of IPV survivors, networks of
specialized community-based organizations (CBOs) support the short- and long-term needs of people seeking
to leave violent relationships. Despite their important roles, both service delivery sites face discrete and well-
documented challenges in meeting survivors’ needs; few efforts have been made to characterize facilitators of
successful transitions for IPV survivors, interrupting a potential pathway for survivors seeking safety from
abuse. The purpose of this study is to identify the facilitators of coordinated care allowing us to access
the levers of change to create a reliable system of care coordination that is feasible, viable and,
importantly, acceptable to all stakeholders, including IPV survivors, hospital and CBO staff. The results
of this R21 will inform intervention development using two complementary but distinct approaches—
Intervention Mapping and community-based participatory research (CBPR). We will accomplish this goal by
conducting 30 in-depth interviews with IPV survivors, hospital and CBO staff to determine individual,
interpersonal and organizational levers of change and facilitators of coordinated care resulting in a logic model
of change. We will also conduct six focus group discussions (up to 10 participants in each) with IPV survivors,
hospital and CBO staff to generate intervention themes, components, scope and sequence. Lastly, in
collaboration with a community advisory board of key stakeholders (n=6), we will validate the logic model of
change and finalize intervention design. These interrelated aims will provide data to develop standard
operating procedures for IPV coordinated care, which can be rolled out and measured in the intervention
production phase in future work. We anticipate that our findings will produce a model process for building IPV
care coordination, ensuring that IPV survivors are connected to the community-based care they need.

Public health relevance
PROJECT NARRATIVE The purpose of this study is to identify the facilitators of coordinated care allowing us to access the levers of change to create a reliable system of care coordination for survivors of intimate partner violence (IPV) that is feasible, viable and, importantly, acceptable to all stakeholders, including IPV survivors, hospital and community-based organization (CBO) staff. We will accomplish this goal by conducting 30 in-depth interviews with IPV survivors, hospital and CBO staff to characterize facilitators and levers of change resulting in a logic model of change informing intervention development for IPV coordinated care in the emergency department setting, and through six focus group discussions with the same key stakeholder groups, we will generate intervention themes, components, scope and sequence. In collaboration with a community advisory board, we will finalize the logic model of change and intervention design for IPV coordinated care, ready for roll out and testing in the intervention production phase of future work.